Clinical Core

CLINICAL CORE
The Penn PET Addiction Center of Excellence (PACE) will provide the infrastructure and resources needed to
promote PET neuroimaging studies by investigators currently conducting funded clinical addiction research at
the Penn and Yale Schools of Medicine. The Clinical Core will provide the clinical services required to conduct
planned pilot projects and subsequent projects identified beginning in year two of the P30 grant period. The
Clinical Core will leverage existing clinical research resources at the Center for Studies of Addiction, a well-
established center at the PSOM, other clinical resources in Philadelphia, and those in New Haven, CT. The
Clinical Core will provide specialized expertise in the recruitment and assessment of patients with opioid use
disorder (OUD) and healthy control subjects (HCs). To recruit participants with OUD, the Clinical Core will
collaborate with two nearby residential addiction treatment programs, the Kirkbride Center and Snyder House,
in which patients are detoxified and maintained drug free for up to three months. These programs are near the
Penn campus in Philadelphia, which ensures that patients can easily be transported to the PET facilities for
imaging. The Clinical Neuroscience Research Unit at the Connecticut Mental Health Center will serve a similar
purpose for OUD patients at Yale. The Clinical Core will also recruit, screen, and evaluate a sample of opioid-
exposed HCs who will be matched to the OUD subjects on key variables. Using a core battery of assessments,
to which project-specific assessments and procedures will be added, the Clinical Core will promote the joint
analysis of findings across the pilot projects and enable investigators to compare HCs who undergo imaging
using more than one PET ligand. The Clinical Core will also manage the clinical data and their integration with
those obtained by the Imaging Core to ensure the efficient generation of study findings and access to the data
repository by investigators in the scientific community locally, regionally, and nationally. These activities will
streamline recruitment, the evaluation of eligibility, the collection of research data, and the seamless integration
of clinical and imaging activities for all pilot projects proposed in the Center. Finally, the Clinical Core will provide
regulatory assistance to pilot project investigators to ensure compliance with all local and national regulatory
requirements. These contributions will help the PACE provide unique insights into the risk and pathophysiology
of OUD and the identification and development of more efficacious treatments for pain and OUD.